Deciphering Immunopathogenesis of MUCORmycosis to ADVANCE Risk stratification, Diagnosis and Management of the Disease

PROJECT SUMMARY/ABSTRACT
Mucorales fungi cause mucormycosis (MCM), a lethal infection in susceptible hosts suffering from diabetic
ketoacidosis (DKA), neutropenia, undergoing hematopoietic stem cell or solid organ transplant, or receiving
corticosteroids. MCM has poor prognosis, with overall mortality rate of 50% that approaches 100% in certain
patient populations. This poor survival is due to limited knowledge about MCM pathogenesis and the immune
response to the infection. There is also lack of understanding of the molecular factors that lead to MCM and/or
predict response to therapy as well as a paucity of effective assays that can inform early diagnosis and response
to antifungal therapy. Importantly, research advances made in the field have largely been slow, and in silo. This
Program Project, MUCORmycosis to ADVANCE risk stratification, diagnosis, and management of the disease
(MUCOR-ADVANCE), consists of three integrated, complementary projects supported by three cores. The goal
of MUCOR-ADVANCE is to decipher the immunopathogenesis of MCM and use this knowledge to develop new
diagnostic assays and approach to therapy. MUCOR-ADVANCE is led by world leaders in MCM research, who
have collaborated for >20 years in the field. This multidisciplinary proposal will uncover key fungal and host
factors that mediate the pathogenesis of MCM and that will be used to as a basis for innovative approaches for
early diagnosis of MCM and host- and pathogen-directed adjunctive immunotherapeutic strategies to attenuate
Mucorales virulence, reverse immunometabolic defects, and harness physiological immune responses against
MCM. Project 1 will delineate the role of unique Mucorales toxins and invasins in the immunopathogenesis of
MCM and assess their use as targets for adjunctive immunotherapy and diagnosis. Project 2 will examine the
role of metabolic abnormalities in impairing specialized host defense mechanisms against Mucorales with
emphasis on immunometabolic strategies focused on free fatty acids and bioactive lipids that mediate the anti-
Mucorales activity of phagocytes. Project 3 will use patient samples to identify surrogates of dysfunctional innate
effector responses and their prognostic significance in MCM patients and will assess mainly FDA-approved non-
cellular immunomodulators (immune checkpoint inhibitors, hematopoietic growth factors, and cytokines) as novel
adjunctive therapies in clinically relevant murine models of MCM. All aims will validate the translatability of the in
vitro and in vivo models by using specimen prospectively collected by the Clinical Core from MCM patients. The
molecular immunopathogenesis studies of MCM will be facilitated by advanced single cell RNA-seq, dual
RNAseq and bioinformatic analyses provided by the Genomic/Transcriptomic Core. Finally, an Administrative
Core will enable the efficient, cost-effective implementation of the goals of the program. The outcome of the
MUCOR-ADVANCE Program project will identify early diagnostic and prognostic biomarkers for improved
disease management and introduce novel immune-based adjunctive therapies. These therapies include FDA-
approved drugs with the potential to rapidly enhance treatment of this lethal disease.

Public health relevance
PROJECT NARRATIVE Mucorales fungi cause mucormycosis (MCM), a lethal infection afflicting susceptible hosts suffering from diabetic ketoacidosis, neutropenia, those undergoing hematopoietic stem cell or solid organ transplant, receiving corticosteroids, or those suffering from severe trauma. This program project will study integrated and complementary themes focusing on key fungal and host factors that promote the disease. The outcome will be used to introduce better disease risk-stratification and prediction of treatment outcome, improved diagnostics of the infection, and augmented novel therapies leading to enhanced management of MCM.